Beta1-selective blockade for prevention of postmenopausal bone loss: A randomized controlled trial

Osteoporosis is a disease of aging that leads to ~2 million fractures and ~$17 billion in healthcare costs
annually. Although several drugs are FDA-approved for the treatment of osteoporosis, the potential for serious
side effects (e.g., osteonecrosis of the jaw, atypical femur fractures) has led most physicians to use these
drugs only for the treatment, but not the prevention, of osteoporosis. This has led to the current situation where
most postmenopausal women must wait until they develop frank osteoporosis (i.e., fractures, or sufficiently
high fracture risk) to begin drug therapy. As such, there is a compelling need for novel, relatively low-risk and
low-cost pharmacological approaches to prevent osteoporosis.
The current proposal aims to translate evidence from rodent studies showing that the sympathetic nervous
system (SNS) is an important regulator of bone metabolism to a simple, cost-effective, and safe approach for
osteoporosis prevention. In key Preliminary Data, we obtained multiple lines of evidence to establish clearly the
role of the SNS in regulating human bone metabolism. A critical component of these data was a “proof-of-
concept” interventional study demonstrating that β1-selective blockers (atenolol, nebivolol), but not a non-
selective β-AR blocker (propranolol), have favorable effects on bone turnover and bone mineral density (BMD)
in postmenopausal women. Based on these data, we will perform a randomized, double-blind, placebo-
controlled 2 year clinical trial addressing the following Specific Aims: (1) Test the hypothesis that treatment
with a widely used, inexpensive, and relatively β1-selective blocker (atenolol) will prevent bone loss at the
lumbar spine and femur neck as assessed by dual-energy X-ray absorptiometry in 420 postmenopausal
women without pre-existing osteoporosis (Aim 1a); and evaluate the tolerability and safety of atenolol when
used for the prevention of bone loss (Aim 1b). (2) Evaluate the effects of atenolol on trabecular and cortical
bone microarchitecture using high resolution-peripheral quantitative computed tomography (Aim 2a), on bone
turnover markers (Aim 2b), and test whether baseline measures of bone turnover or of sympathetic activity
(resting heart rate, plasma catecholamine levels) are predictive of the BMD response to atenolol over 2 years
(Aim 2c). (3) In a subset of patients, explore the underlying molecular and cellular mechanisms for the effects
of β1-selective blockade on bone in humans using analyses of osteoblast populations isolated from bone
biopsies as well as tissue-level bone formation rates on quadruple-labelled bone biopsies (Aim 3).
The proposed studies will rigorously test whether atenolol is efficacious and safe for the prevention of
osteoporosis in postmenopausal women and also further define the mechanisms of SNS effects on bone in
humans. If our proposed clinical trial demonstrates protection from bone loss in postmenopausal women by
atenolol, this would fill a crucial clinical need, as these women currently have virtually no pharmacological
options for osteoporosis prevention.

Public health relevance
Osteoporosis is a disease of aging that leads to ~2 million fractures and ~$17 billion in healthcare costs annually. Based on key preliminary findings, our proposal aims to translate evidence from rodent studies showing that the sympathetic nervous system is an important regulator of bone metabolism to a simple, cost- effective, and safe approach for osteoporosis prevention. Specifically, we will test whether a commonly used cardiovascular drug, atenolol, can prevent bone loss over 2 years in postmenopausal women.